Radiation Sterilizable Small Size RFID Tags for Biomedical Samples

DESCRIPTION (provided by applicant): The Specific Aim of this Phase I SBIR proposal is to test the feasibility of producing small, sterilizable RFI tags for use in ultra-low temperature storage samples vials. Many of millions of new biological samples are stored annually at research facilities, universities, hospitals, biobanks, pharmaceutical companies, etc. For the most part, tracking these samples is carried out manually or at best, using 1D or 2D bar codes. In many biobanks, regulations demand that all samples must be accounted for at all times and manual inventories are carried out on a regular basis. Performing these inventories by hand can cost a biobank thousands of person hours per year. In the case of samples in ultra-low temperature biobanks, manual searching for samples inevitably warms them and degrades them. Our company has addressed this problem for the ubiquitous 5.25 sample box. We have developed a unique RFID based method of tracking individual vials and boxes in the freezer of a biobank in real time. We are currently selling products and continue to develop that product line, but there are two significant barriers to more widespread use of RFID tags in the biomedical community. One is that current RFID tags cannot be sterilized in the same way as the vials they are meant to tag. The other is that the fastest growing market, SBS 96 formatted vials, is not addressed due to the small vial size. While many RFID tags can be sterilized using ethylene oxide or autoclaving, almost all vials are sterilized using either electron beam (e----beam) or gamma irradiation. Typical RFID tags are destroyed by both of these processes. In practice, this means that RFID tags and vials need to be attached after the sterilization process using sterile methods. This is not a practical solution because it adds additional handling and procedural steps and is prone to human error. We propose to develop an RFID tagged vial that will fit the SBS----96 formats and that can be sterilized using e beam or gamma irradiation. To achieve our Specific Aim, we will carry out the following tasks: Task #1: Develop a prototype RFID tag that will fit in an SBS----96 vial. Task #2: Make the RFID tag resistant to radiation sterilization. In Phase II, we will develop a commercial manufacturing method for producing encapsulated and sterilizable RFID tags as well as the supporting hardware and software for reading the tags. We expect to have a finished product at the end of Phase II.

Public health relevance
PUBLIC HEALTH RELEVANCE: The number of archived biological samples is very large and ever growing. Maintaining large collections of these samples is fraught with difficulties arising from inadequate labeling technologies, the inability to automatically locate the samples and a lack of robust connection between the physical sample and archiving software. We propose to develop small, encapsulated, sterilizable RFID tags that can be built into modern sample vials and sterilized in situ. This will bring the advantages of RFID technology to the many forms of sterile plastic ware used in the biomedical community. This will reduce human errors, save cost, allow locating samples, and will minimize the need to handle frozen samples.